A novel spatial biology platform for protein profiling which is cost effective and scalable

ABSTRACT
Spatial biology platforms are revolutionizing the study of biology and are rapidly becoming indispensable for the
understanding and treatment of cancer. However, the platforms on the market now, whether for proteomics
profiling or transcriptomics analyses, are costly and are not scalable for widespread adoption. Current imaging-
based approaches used for proteomics profiling provide exquisite detail but are slow and are limited in the
number of protein targets that can be analyzed on a single tissue slide. Imageless systems allow simplified data
acquisition via next generation sequencing (NGS) readouts but these platforms have difficulty achieving
subcellular resolution. The goal of this application is to develop a scalable, low-cost, image-free spatial biology
platform with sub-cellular resolution that is suitable for adoption into basic research and CLIA environments. The
proposed project is based on proprietary barcoded tags that enable a unique isothermal workflow that allows
information transfer to a spatially encoded array in a single hands-free step. The workflow is non-destructive to
the tissue and requires no specialized instrumentation to produce digital “images” of protein presence and
abundance at sub-cellular resolution. The goal of this proposal is to combine technologies licensed by RyboDyn,
Inc. to create a novel platform that enables coordinate spatial and architectural analysis of cellular proteomic
profiles for deployment into research as well as clinical labs. This proposal aims to: 1) Demonstrate a semi-
ordered spatial capture array; 2) Demonstrate sub-cellular resolution of a 4-plex panel of DS-tag labeled
antibodies. At the conclusion of this phase, we will have 1) Demonstrated a novel spatial capture array that is
useful for the spatial encoding of information retrieved from bound antibody probes conjugated with RyboDyn’s
proprietary tags, and 2) Demonstrated the isothermal spatial encoding workflow with decoding of the retrieved
information by NGS, to enable digital display of protein profiles in biological samples.

Public health relevance
Project Narrative Commercially available platforms for spatially-resolved protein profiling of 2D tissue sections are costly and time consuming, which hinders their widespread adoption in basic research as well as in the clinical settings. This proposal aims to overcome barriers that are critical for the development of a low-cost and scalable platform for spatially-resolved protein profiling, by enabling quantitative, image-free detection of multiple biomarkers in highly parallel fashion, to produce digital proteomic profiles at sub-cellular resolution. The platform and workflow proposed are designed to be commercially viable and widely adopted by researchers and clinicians.